Immune Mechanisms of Protection Against Mycobacterium Tuberculosis Center (IMPAC-TB)

The goal of this program is to establish an integrated multi-disciplinary team of highly collaborative investigators that will plan and conduct iterative, in-depth immunologic analyses of tissue-specific and systemic responses in small animals, non-human primates (NHPs), and humans to identify the key immune responses needed for protection against Mtb; identify immunologic targets that can be used to improve TB vaccine strategies. Other research activities under the program may include determining the impact of HIV/SIV and Nontuberculous Mycobacteria (NTM) infection(s) on relevant immune responses to Mtb infection or TB vaccines and identifying how bacterial immune evasion mechanisms subvert immune responses to Mtb. As part of the overall scope of work, this contract is currently conducting a Phase I TB Vaccine Clinical Trial to test the efficacy of a TB vaccine candidate.